Development Core-003

DEVELOPMENTAL CORE ABSTRACT
The Developmental Core (DC) supports the mission of the University of Alabama at Birmingham (UAB)'s
Center for Cancer Control in Persistent Poverty Areas (C3P2) to reduce the burden of cancer and cancer
disparities in Persistent Poverty (PP) areas by expanding research and research capacity through
implementation and evaluation of multilevel interventions to improve cancer outcomes across the cancer
control continuum from prevention to survivorship. The DC expands research in cancer control in (PP) areas
of Alabama by developing a research program that builds on the overarching research framework and the
proposed research projects. This goal will be achieved by identifying and developing pilot projects in synergy
with the C3P2 Community Advisory board (CAB) and the National Cancer Institute (NCI)'s Persistent Poverty
Initiative Network (PPIN). The DC will bring together C3P2 investigators, including trainees from the Career
Enhancement Core (CEC) and CAB members in a process to identify, select, and prioritize the most relevant
and feasible pilot projects. Participation in cross-PPIN centers' collaborative projects will also be considered in
this process. With this plan, the DC ensures that pilot projects address the needs and context of PP census
tracts and fall within the themes of C3P2 and within the larger goals of the PPIN. Potential pilot projects will
build on the current projects that examine the impact of changes in the Living Environment and the adaptation
of efficacious interventions to improve cancer outcomes in PP areas, and may investigate multi-level
interventions to address needs such as low food access and lack of transportation, as well as specific needs to
improve cancer survivors' health. The DC also support the C3P2 mission of expanding research capacity in
PP areas by providing research experience opportunities to CEC trainees and other investigators not affiliated
with the center, and requiring pilot projects have at least one early career investigator as PI or investigator. All
projects will be peer-reviewed to ensure scientific rigor and integrity. The DC will have at least two active
projects in each funded year. Lastly, the DC will support the development and implementation of the pilot
projects by coordinating the use of resources from the Research and Methods Core (RMC) and the
Administrative Core (AC), supporting investigators with IRB applications, training, identifying personnel as
needed, and evaluating progress. Thus, the DC is well poised to successfully support the C3P2 and contribute
to the goals of the PPIN.